Deimplementation of Inappropriate Feeding Practices in Early Care andEducation Settings

Project Summary
More than 12 million children in the U.S. consume up to two-thirds of their dietary intake in early care and
education (ECE) settings.1,2 Yet, educators in ECE often use dietary and feeding practices that are not
evidence-based.3 Given that childhood dietary habits often persist into adulthood,4–6 failure to use evidence-
based practices (EBPs) related to healthy nutrition and feeding patterns can have negative implications for
development of weight trajectories and dietary patterns across the lifespan. The overall objective for this
application is to determine the effectiveness and associated mechanisms of a package of deimplementation
strategies to reduce the use of inappropriate feeding practices in ECE. Demonstrating the effectiveness of
strategies for reducing inappropriate feeding practices in ECE and determining how the strategies work and for
whom will provide new opportunities for building a strong foundation in the ECE setting for lifelong healthy
eating habits. We will conduct a cluster-randomized Hybrid Type III trial with 88 ECE sites serving children
ages 3 and 5. The trial will achieve two specific aims:
Aim 1: Determine the effectiveness of a package of deimplementation strategies for reducing the
use of inappropriate feeding practices in ECE. Our hypothesis is that, compared to usual practice, the
deimplementation strategies will be effective at reducing the total number of observed inappropriate feeding
practices per meal, our primary deimplementation outcome (N= 88 sites, 528 educators).3 We will also identify
effects on secondary effectiveness outcome measures including child body mass index, willingness to try novel
foods, fear of new foods (i.e., neophobia), and dietary intake (N=1320 children).
Aim 2: Identify mechanisms of deimplementation using a mixed methods approach. Our hypothesis
is that factors specified by the Implementation Trust Building Theory of Change22 will mediate the effect of
strategies on deimplementation outcomes. Using an explanatory, sequential design, we will collect qualitative
data with purposively selected educators (N = 32) to identify emergent mediators and moderators.
The project will determine the effectiveness of a blended in-person and virtual approach to
deimplementation with scalable tailoring elements. In addition, we expect to have determined key mechanisms
of our deimplementation strategies, providing practice-relevant information on how and why strategies work to
change behavior in the real world and informing future replication and scale-up. These results are expected to
have a positive impact on the weight and dietary behaviors of young children through the targeted removal of
inappropriate feeding practices in ECE.

Public health relevance
PROJECT NARRATIVE Arkansas and Louisiana have among the highest rates of adult obesity in the United States at 38.7% and 38.6%, respectively. Prevention and intervention efforts are needed to reduce the number of children who will become obese adults and suffer the host of negative health consequences that accompany it. This proposal will develop and test strategies to stop the use of detrimental feeding practices by early childhood educators which promote unhealthy weight trajectories, inappropriate eating behaviors and poor dietary outcomes for children.